Coronary artery calcium synthetic cohort and lifetime percentile project (CACSC-LPP)

Coronary artery calcium (CAC) testing provides a direct measure of an individual’s atherosclerotic burden that
is robustly associated with cardiovascular disease (CVD) risk. Accordingly, CAC scoring has a IIa
recommendation in the 2018 AHA/ACC Cholesterol Treatment and 2019 ACC/AHA Primary Prevention
Guidelines and is also recommended by many other national and international guidelines for the allocation of
primary prevention medications. The clinical implications of the Agatston score can vary significantly based on
the age, sex, and race/ethnicity population percentile score, which is particularly crucial for estimating long-
term or lifetime CVD risk, especially for younger persons in whom a low Agatston score may commonly be
reflective of premature atherosclerosis and significantly increased lifetime risk. However, current guideline-
recommended CAC percentile scores were developed from only one NHLBI cohort comprised of
predominantly middle-aged participants and there is no centralized website or resource with all the available
tools to facilitate interpretation of the CAC score. Consequently, there is an unmet need to 1) develop CAC
percentile data across the lifespan that is more representative of the US population and more diverse across
racial/ethnic minorities, particularly South Asians, who have a significantly increased CVD risk yet are not
included in current percentile score calculators and 2) create a centralized website and mobile app to aid in the
interpretation of CAC at the point of care. Therefore, using standardized data harmonization techniques, we
propose to pool data from 7 NHBLI cohorts and 3 real-world clinically-derived cohorts to create the gender-
balanced, racially/ethnically diverse CAC Synthetic Cohort Lifetime Pooling Project (CACSC-LPP) of
approximately 20,000 NHBLI participants with CAC data across the lifespan (age 30-95 years old) and an
additional ~90,000 participants from clinical CAC cohorts. Harmonizing the individual participant level data will
pragmatically leverage the enormous NIH investment (monetary and time) in these cohorts to create a new
pooled dataset that expands the clinical impact beyond what was originally envisioned. It will also create an
ideal foundation to iteratively expand the CACSC-LPP to ensure better representation for all persons living in
the US, with an initial focus on South Asians. Additionally, we will build upon our prototype CAC-tools website
and companion app so that clinicians and patients can enter a CAC score (plus any other available risk factor
data) and retrieve their CAC percentile. This website/app will serve as the definitive source for all CAC related
tools and would be well positioned to be endorsed by future national CVD guidelines (see LOS, Drs. Lloyd-
Jones & Arnett). Through the creation of the 1) CACSC-LPP, 2) CAC percentile calculator across the lifespan,
and 3) centralized CAC website/app this project will improve personalized CVD risk prediction, implementation
of ACC/AHA primary prevention recommendations, while also creating the infrastructure for multidisciplinary
and cross-institutional collaborations to further improve our understanding of CAC for CVD risk prediction.

Public health relevance
Coronary artery calcium (CAC) testing provides a direct measure of an individual’s atherosclerotic burden that is robustly associated with cardiovascular disease risk and is recommended by national and international guidelines for the allocation of primary prevention medications. Currently, there is a lack of data on sex and race/ethnicity-specific CAC percentiles across the lifespan that is representative of the whole US population and there is no centralized website/resource to guide clinical interpretation of CAC scores. We will combine 10 datasets to create a harmonized CAC Synthetic Cohort Lifetime Pooling Project (CACSC-LPP) enabling calculation of sex and race/ethnicity CAC percentiles across the lifespan that will be translated into a website/app to serve as the definitive resource for interpretation of CAC scores.